Neural algorithms underlying diversity in visual feature integration

PROJECT SUMMARY
We here focus on determining the algorithms that enable highly similar visual information to be transformed into
diverse, behaviorally relevant outputs. We also seek to determine the mechanisms that generate these
algorithms. Understanding how visual information is transformed into representations relevant for behavior is
key for restoring sensorimotor transformations in those who are blind or visually impaired, or suffer from sensory
processing disorders. For our visual inputs, we use looming stimuli, the 2-D projections of an object approaching
on a direct collision course. Looming stimuli elicit a conserved diversity in behavioral responses across species
that are necessary for survival. This diversity is thought to emerge through parallel sensorimotor processing
pathways that differentially transform visual features of a looming stimulus into motor outputs. Limited access
to both visual feature encoding and visual feature integrating circuit components has however limited the
development and biological validation of the algorithms utilized across pathways. We circumvent these
limitations by using Drosophila melanogaster that provides the necessary electrophysiological and genetic
access to the cell types that participate in these sensorimotor transformations. Our preliminary data suggest
looming information is transformed within eight descending sensorimotor pathways (DN) that receive features of
looming stimuli from up to six optic lobe columnar projection neuron (OLCPN) cell types. In this interdisciplinary
grant, we capitalize on the complementary expertise of Dr. von Reyn (PI), who has pioneered
electrophysiological, behavioral, and genetic methods for investigating feature integration within OLCPN and
DN, and Dr. Ausborn (co-PI), who has broad expertise in the development of mechanistic biophysical circuit
models for the analysis of neural computations within mammalian and invertebrate systems. Here we
characterize the extent to which different DN intrinsic properties and circuit mechanisms account for the observed
output diversity. In Aim 1 we combine electrophysiology, RNAi silencing, and computational modeling to
establish, at a molecular level, intrinsic integration mechanisms for each DN. In Aim 2, we combine
electrophysiology, optogenetics, and computational modeling to determine OLCPN synaptic inputs to DN. In Aim
3, through concurrent model and experimental probing, we evaluate the dominant mechanisms that determine
looming feature integration algorithms utilized across the DN population. This project will provide a thorough
understanding of general principles for transforming sensory information into higher order, behaviorally relevant
representations.

Public health relevance
PROJECT NARRATIVE Those who are blind or visually impaired suffer from an inability to transform visual information into behaviorally relevant representations to guide selection of appropriate actions. This project seeks to derive the algorithms for sensorimotor transformations that can guide technologies to restore visual-motor behaviors through neuroprosthetics. This project also seeks to uncover the underlying mechanisms for these algorithms that provide targets for restoring sensorimotor transformations in neurodegenerative diseases or neurodevelopmental disorders.